Improving dog vaccinations: a development and feasibility study to pave the way for effective, synchronized dog vaccination campaigns in Africa

Title: Improving dog vaccinations: a development and feasibility study to pave the
way for effective, synchronized dog vaccination campaigns in Africa
Dog-mediated human rabies has the highest case fatality rate of any known disease and kills
approximately 59,000 people annually particularly in Asia and Africa, where people are
infected following bites from rabid dogs. Vaccination of at least 70% of the dog population is
100% effective in preventing the spread of rabies to humans. However, achieving 70%
coverage can be difficult across large geographic areas. Traditional dog vaccination in East
Africa involves teams of vaccinators moving village-to village across a district. Under this
team-lead approach, campaigns last 30 to 60 days depending on available personnel and
geography. Although this approach sometimes works, its execution at scale is challenging,
expensive, and time-consuming.
The objective of the proposed research is to carry out an implementation trial to investigate
the potential of synchronized dog vaccinations which have been highly successful in Latin
America. Such synchronized campaigns could benefit massively from a coordinated mass
media campaign in the lead-up before the vaccination day. We will investigate whether
combined media and synchronized campaigns can improve vaccination coverage.
Our first hypothesis is that synchronized campaigns will increase dog owners’ participation in
MDV. Our second hypothesis is that synchronized campaigns will lead to the large number
of dogs being vaccinated, resulting in reduction in the overall delivery cost. Our final
hypothesis is that synchronized MDV delivery will result in improved public health outcomes
and achieve elimination more rapidly than standard team-led MDV.
Dog vaccination will be carried out into six districts in a 3-arms of the implementation trial (2
districts per Arm). We will compare (i) vaccination coverage, (ii) cost per dog vaccinated and
(iii) health impacts in Arm A: team-led delivery (which is logistically challenging and results in
irregular coverage, at cost), versus Arm B: synchronized campaigns without media
intervention and Arm C: synchronized campaigns and media intervention.
With a date of 2030 set by WHO/OIE/FAO for the global elimination of dog-mediated human
rabies, these results are needed to guide elimination in dog-rabies endemic countries

Public health relevance
Title: Improving dog vaccinations: a development and feasibility study to pave the way for effective, synchronized dog vaccination campaigns in Africa Despite dog-mediated human rabies can be eliminated through mass dog vaccinations, dog vaccinations have not been scaled-up in Africa, whereby, pilot campaigns conducted through a standard centralized team-led delivery have sometimes failed to achieve the required (70%) level of coverage that is necessary to interrupt rabies transmission. There is a lack of practical and evidence-based methods for scaling-up dog vaccinations to support global target set for elimination of human deaths by 2030, therefore, I will conduct implementation trial of synchronized mass dog vaccinations supported by mass media, to answer key questions related to the coverage, cost per dog vaccinated, and human health impacts of synchronized vaccination campaigns versus team-led delivery. I anticipate that this study will lay ground for future scale up of mass dog vaccination in East Africa and potentially other settings in sub-Saharan Africa.